Pathogenesis of Systemic Juvenile Idiopathic Arthritis-Associated Lung Disease

PROJECT SUMMARY / ABSTRACT
Severe lung disease is an increasingly recognized life-threatening complication of systemic juvenile idiopathic
arthritis (SJIA-LD), representing a distinct and highly inflammatory interstitial lung disease that affects as many
as 1 in 20 children with SJIA. While the etiology of SJIA-LD is unknown, it is strongly linked to macrophage
activation syndrome, (MAS), episodic systemic hyperinflammation with SJIA that is driven by interferon gamma
(IFNγ). We recently reported that SJIA-LD and MAS share prominent features of IFNγ activation, supporting a
key role for this pathway in the pathogenesis of SJIA-LD. However, the mechanisms by which IFNγ activation
drives pulmonary inflammation in SJIA-LD is unexplored. In addition, the widespread use of anti-IL-1 therapy for
SJIA has been linked to markedly increased incidence of SJIA-LD including distinct clinical features and
development of pulmonary alveolar proteinosis (PAP). Our proposed studies provide a critical step to identify the
mechanistic causes of SJIA-LD, a necessary step towards developing targeted treatment strategies for and
ultimately to prevent SJIA-LD. The objective of this application is to define the mechanisms by which MAS and
persistent IFNγ drive the pathogenesis of SJIA-LD. Accordingly, our central hypothesis to be tested is that
persistent IFNγ pathway activation leads to alveolar macrophage dysfunction and lung inflammation in SJIA-LD
and is amplified by anti-IL-1 biologic therapy. To study the mechanisms of SJIA-LD, we will utilize overlapping
approaches in our established mouse model system to directly test effects of persistent IFNγ on pulmonary
inflammation, and the requirement of IL-1 signaling for alveolar macrophage functional phenotypes. In parallel,
we will define IFNγ-driven functional polarization phenotypes of alveolar macrophages in children with SJIA-LD.
Specific Aim 1 will determine whether persistent IFNγ activation is the key driver of lung inflammation during
MAS. We hypothesize that persistent IFNγ activation during chronic/recurrent MAS leads to the development of
lung disease in mice. Specific Aim 2 will identify mechanisms of alveolar macrophage reprogramming in
experimental MAS. We hypothesize that IL-1 blockade in the setting of persistent IFNγ activation during MAS
reprograms alveolar macrophages towards inflammatory phenotypes and inhibits anti-inflammatory/resolution
and homeostatic functions. Specific Aim 3 will define IFNγ-driven alveolar macrophage populations in children
with SJIA-LD. We hypothesize that alveolar macrophage subsets in SJIA-LD display an IFNγ-driven inflammatory
phenotype that prevents normal homeostatic functions. We anticipate that the proposed experiments will define
the function of persistent IFNγ activation and IL-1 blockade as drivers of lung inflammation and alveolar
macrophage dysfunction in MAS and SJIA-LD. Together these studies will advance our long-term goal of
identifying the causes of and developing novel treatment approaches for SJIA-LD.

Public health relevance
Project Narrative The proposed research is relevant to public health because severe lung disease (LD) is an emerging complication of systemic juvenile idiopathic arthritis (SJIA) and macrophage activation syndrome (MAS) has rapidly become the leading cause of death for children with this disorder. The proposed aims will mechanistically define the role of IFNγ as well as IL-1 blockade in an experimental model of lung disease in MAS as well as children with SJIA-LD, informing clinical care and leading to rapid translation of new therapeutic avenues. The project is relevant to NIH’s mission through seeking fundamental knowledge about the nature of systemic cytokine storms, and applying that knowledge to influence established treatment paradigms in SJIA, particularly with regards to the continued use of biologic therapy and risk of SJIA-LD.